Self-Management for Youth Living with Sickle Cell Disease (SMYLS)

PROJECT SUMMARY/ABSTRACT
Sickle cell disease (SCD) is a chronic condition that affects every organ system and requires lifelong
complicated treatment regimens. Adolescents and young adults (AYA) with SCD experience remarkable
increases in negative outcomes (e.g., morbidity, mortality, complications, acute care utilization) following
transition from pediatric to adult care. To mitigate negative outcomes, it is critical that AYA with SCD develop
effective self-management behaviors prior to transition to adult care. However, AYA with SCD face challenges
to self-management behavior development that are compounded by the lack of easily accessible self-
management tools. Our long-term objectives are to develop a comprehensive model of self-management for
AYA with SCD that incorporates mechanisms of self-management behavior development and influencing
modifiable and fixed factors, along with a clinical model of care that addresses mechanisms and influencing
factors and provides AYA and providers with resources to improve self-management behaviors. This R01
application to the National Institute of Nursing Research (NINR), Self-Management for Youth Living with
Sickle Cell Disease (SMYLS), will advance us towards this objective by supporting: 1) effectiveness testing of
our existing, theoretically founded, mHealth self-management intervention and 2) assessment of the role of
patient activation on self-management behavior development. In Aim 1, we will examine the pre-post
intervention differences in engagement in self-management processes, self-management behaviors, health and
quality of life outcomes, and the relationships among patient activation and outcomes. In Aim 2, we will
determine barriers and facilitators to adoption of the self-management intervention to inform future
implementation initiatives. In the Exploratory Aim, we will identify socioenvironmental and psychosocial
modifiable and fixed variables that influence outcomes. Findings from this study will determine the
effectiveness of a theoretically founded, mHealth self-management intervention for AYA with SCD, identify the
role of patient activation in self-management for AYA with SCD, and characterize influences on self-
management behaviors. In addition, if the intervention is proven effective, findings on barriers and facilitators
to intervention adoption in this study can be applied to the next step in this research trajectory, wide-scale
implementation of the intervention. Our objectives are consistent with the 2022 – 2026 National
Institute of Nursing Research Draft Strategic Plan to reduce disease severity, symptoms, and
progression with a focus on reducing health disparities by targeting improved self-management behaviors pre-
transition to adult care to mitigate subsequent negative outcomes in AYA with SCD, a population that has been
underserved in research and healthcare advancements.

Public health relevance
PROJECT NARRATIVE Risks of complications and death for adolescents and young adults (AYA) with sickle cell disease (SCD) increase dramatically following the transition from pediatric to adult care. To reduce these risks, it is critical that AYA with SCD develop self-management skills prior to transition to adult care; however, easily accessible tools to assist with SCD self-management skills development are scarce. This study will support the testing of a web-based application (app) that provides AYA with SCD with tools and resources to develop self-management skills that can reduce risks of complications and death.